Neural Mechanisms of Menstrual Cycle Effects on ADHD and Cognition

ABSTRACT
Attention-Deficit/Hyperactivity Disorder (ADHD) is increasingly recognized as a serious and debilitating
problem in adolescent and adult females, with impairment and comorbidity in female patients with ADHD
increasing dramatically around puberty. Given the deleterious consequences of ADHD and substantial
comorbidities in this group, there is an urgent need to understand sex-specific factors contributing to symptom
expression in this understudied population. One promising but understudied factor is ovarian hormones which
become activated around puberty and fluctuate monthly in adulthood. To date, no study outside of our lab has
examined the effects of estrogen and progesterone changes on ADHD symptoms in female patients, but basic
science data from animal studies provide a strong scientific premise for this work. These studies date back 20
years and suggest that withdrawal from—and lower levels of—estradiol, the predominant estrogen, cause
cognitive and attention problems, based on experimental work with ovariectomized rats. In fact, we have pilot
data establishing the basic scientific premise and feasibility of this study design showing declines in estrogen
predict worsening response inhibition and working memory and increases in ADHD symptoms in a clinical
sample of female patients with ADHD. Yet, it remains unclear what accounts for these effects at the
neurobiological level in humans, despite animal work showing estrogen effects on dopamine and human work
in female heavy drinkers showing estrogen effects on insular brain activation patterns during response
inhibition tasks. The current project aims to use an innovative, quasi-experimental, and intensive longitudinal
menstrual cycle study design to elucidate the neurobiological mechanisms of estrogen effects on neural
mechanisms of cognition and ADHD symptoms in a clinical sample of 120 young adult female patients ages 18
to 25 with ADHD. The project will evaluate whether menstrual cycle phase and hormonal effects on the neural
circuitry involved in response inhibition and working memory predict short-term longitudinal change in ADHD
symptoms and medication response in young adult females with ADHD. This work is a critical extension of our
preliminary data, which found cycle phase and hormonal effects on ADHD and response inhibition and working
memory but did not evaluate neural mechanisms or hormonal effects on treatment response. The long-term
goal of this project is to test whether medication titration or hormone stabilization across menstrual cycle phase
or reproductive phase improves ADHD symptoms and normalizes underlying neurocognitive and biological
mechanisms in females. Such information is critical to advancing neurobiological theory of ADHD and
suggesting new avenues for personalized, sex-specific assessment and psychopharmacological treatment of
ADHD, which may need to be targeted to cycle or reproductive phase, hormonal profiles, and impacted
neurofunctional regions in pharmacotherapies.

Public health relevance
Narrative The current project will evaluate the neural mechanisms underlying menstrual cycle phase and hormonal effects on response inhibition and working memory in females with ADHD. In addition, the project will determine whether and how well cycle phase and hormonal effects on neural function during cognitive tasks predict ADHD symptoms and treatment response.